Toxic Effects of Anesthetics in Developing White Matter

PROJECT SUMMARY
Based on the best available evidence derived from human epidemiologic studies and animal research
conducted in rodents and non-human primates, the U.S. Food and Drug Administration has issued a warning
that repeated and/or lengthy exposures to anesthetic and sedative drugs between the third trimester and the
third year of life may adversely affect brain development. The mechanism by which these short-acting drugs
could have long-term consequences remains unclear. Nearly all previous research on this topic has been
focused on neurons, however proper functioning of brain circuitry is also heavily dependent on other cell types.
During fetal and postnatal development across mammalian species, oligodendrocytes (OLs) differentiate from
oligodendrocyte precursor cells (OPCs) and generate myelin, which insulates axons to ensure high-fidelity
transmission of electrical signals. Therefore, developing OLs represents a highly plausible and largely
unexplored novel target for anesthetic neurotoxicity. We propose to test the central hypothesis that early
developmental exposure to general anesthesia (GA) interferes with brain development by disrupting myelin
formation. First, we will assess the overall impact of this hypothesis by determining which commonly used GAs
interfere with myelination, identifying GA-induced neurologic deficits that result from impaired myelination, and
testing the effects of GAs on human OL development. Our preliminary data suggests that GAs interfere with
the function of OPCs, which are a pool of precursor cells that are critically important for developmental
myelination. Thus, we will test the hypothesis that GAs act at the cellular level by inhibiting the survival,
proliferation, differentiation, and/or homeostatic interactions of OPCs. Finally, we will test the hypothesis that
GAs exert an epigenetic effect at the molecular level by inhibiting methylation of DNA sequences that regulate
transcription of genes required for myelination. To address these questions, our study will employ innovative,
cutting-edge experimental neuroscience tools, including human embryonic stem cells, conditional transgenic
mice, two-photon in vivo real time imaging and cell ablation, and high throughput sequencing of the
methylome. The experiments of this proposal are expected to define an entirely new mechanism of anesthetic
toxicity. The adult nervous system recapitulates many elements of myelin development as a critical part of the
defense against the devastating effects of demyelination disorders such as multiple sclerosis and amyotrophic
lateral sclerosis and as a key feature of recovery from disabling injuries such as brain trauma and stroke.
Thus, our findings will be significant for pregnant patients and young children, and also for the large population
of adult patients with myelin-related pathology. The enhanced understanding of how anesthetics affect myelin
formation gained here will allow researchers to design studies assessing the risks of anesthetic and/or sedative
exposures in potentially vulnerable patients and to test preventative and treatment strategies to mitigate harm
to those patients who are at risk.

Public health relevance
PROJECT NARRATIVE There are substantial concerns from human, primate, and rodent studies that high levels of exposure to general anesthesia (GA) in early life may result in lasting, harmful effects on brain development that lead to alterations in cognition and behavior. Nearly all previous work in this area has focused on anesthetic effects on developing neurons, but based on exciting new preliminary findings, we propose to explore the novel hypothesis that GA disrupts the formation of myelin, the biological insulation that is critical for electrical transmission, and thus for the proper functioning of brain circuitry. In this project we will use advanced techniques in neuroscience, including laser, multiphoton, and electron microscopy, human stem cells, transgenic mice, and high-throughput sequencing, to understand how GA disrupts myelination at the cellular and molecular level.